01-LOGISTICS FOR NEUROLOGICAL EFFECTS AFTER CHEMICAL NERVE AGENT EXPOSURES NIH WORKSHOP BEING HELD 2/26-27/2014 -- CATALOG # : N/A

LOGISTICS FOR NEUROLOGICAL EFFECTS AFTER CHEMICAL NERVE AGENT EXPOSURES NIH WORKSHOP BEING HELD 2/26-27/2014